Understanding paracrine interactions induced by morphogens in PDAC

PROJECT SUMMARY/ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) is a highly lethal disease characterized by extreme
chemotherapeutic resistance and the lack of effective immune response, fueling the need for effective treatment
strategies. PDAC features include a complex desmoplastic stroma comprising cancer-associated fibroblasts
(CAFs), a variety of lymphoid and myeloid cell lineages, and a plethora of paracrine signals that communicate
between them. Malignant cells attract and reprogram stromal cells through morphogens like Sonic Hedgehog
(SHH) and Transforming Growth Factor beta (TGFβ), creating a hospitable tumor microenvironment (TME)
conducive to survival, growth, invasion, and escape from immune response. However, the underlying
mechanisms mediating stromal reprogramming are understudied. This proposal aims to identify how active
morphogen signaling shapes local immunosuppression in the pancreatic TME by focusing on the interaction of
malignant epithelial cells, CAFs, myeloid cells, and T cells. In the past, targeting either of these populations has
been insufficient to reverse immunosuppression, demonstrating that the complexity of crosstalk between diverse
cell types in PDAC is insufficiently understood. By combining in vivo and ex vivo studies with a novel PDAC
tumor explant platform, we are able to study cell-cell communication in an intact TME by manipulating morphogen
signaling through targeted drugs, recombinant proteins, and neutralizing antibodies. These experimental
approaches are guided by sophisticated computational analyses based on single cell RNA sequencing data. The
overarching goal is to understand how CAFs and myeloid cells collaborate to maintain local
immunosuppression within the pancreatic TME and leverage this understanding to reactivate anti-tumor immune
response in PDAC. I hypothesize that combinatorial CAF and myeloid targeting will disrupt local
immunosuppression and lead to partial reinstatement of T cell action that can be pushed further by
immunomodulators. I will pursue this hypothesis through the following interrelated Specific Aims: In Aim 1, I will
focus on how SHH-activated CAFs regulate the expansion of the myeloid cell population in PDAC. Aim 2 centers
around building and testing a novel treatment regimen to reactivate exhausted T cells. Aim 3 seeks to identify
differences between SHH and TGFβ-mediated CAF activation and downstream paracrine effects in the
pancreatic TME. These studies will identify how malignant epithelial cells, CAFs, and myeloid cells work together
to maintain immunosuppression through an intricate communication network. Successful completion of this
proposal will both expand our basic understanding of PDAC immunosuppression and also produce a practical
advance in the therapeutic targeting of this devastating disease. Concurrently, this work will facilitate my pathway
towards an independent NIH-funded tenure-track faculty investigator by advancing my long-term objective of
dissecting paracrine signaling cascades in PDAC.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is one of the most lethal cancers due to its extreme chemotherapeutic resistance and the lack of effective immune response. Local immunosuppression in the dense desmoplastic stroma is governed by morphogen signaling. This proposal aims to investigate how morphogen signaling influences the communication between epithelial tumor cells, cancer-associated fibroblasts, myeloid cells, and cytotoxic T cells, and exploit these findings for targeted therapy.